Emerging Papillomaviruses in Immunosuppressed Dogs

DESCRIPTION (provided by applicant): Dogs play a central role in laboratory medicine, ranging from studies of toxicology and pharmacokinetics to genetic therapy and bone marrow transplantation. Emerging papillomavirus infections and the tumors that they induce are increasingly complicating the study of immunosuppressed dogs. Defective immune responses in dogs are primarily the consequence of studying new drugs for treating dermatologic, neurologic and immunologic diseases. In addition, pioneering experiments on bone marrow transplantation also interfere with normal host immunity and make dogs susceptible to papillomavirus infection. To address this issue, we propose to identify the canine papillomaviruses responsible for these infections, to evaluate the time at which dogs are infected, and to develop prophylactic vaccines. The ultimate goal of our studies is to develop vaccines that will allow investigators to carry out medical research without being compromised by serious papillomavirus infections.

Public health relevance
(provided by applicant): Dogs provide important laboratory models for the study of human disease and for the evaluation of drug safety. Many of these scientific investigations involve conditions that result in reduced host immunity. Under such conditions, dogs often develop skin tumors that interfere with the completion of the experimental protocol. The goal of this grant is to define whether papillomaviruses are responsible for most of these skin tumors and, if they are, what types of papillomaviruses are involved. Finally, the most important goal is to develop vaccines that can be used to protect the dogs against this viral infection and to prevent the development of tumors.